Chemo-Mechanical Feedback between CAFs, Leader Cells, and the Extracellular Microenvironment Regulates Leader Cell Regulated Collective Cell Migration

Project Summary/Abstract
The impact of cancer associated fibroblasts (CAFs) and the extracellular microenvironment (ECM) in cancer
metastasis has become more and more appreciated. The tumor microenvironment consists of multiple
compartments: cellular, physical, and chemical. Each compartment in cancerous tissues differs greatly from
normal tissue, yet the role that each plays in metastasis and how they affect each other is poorly understood.
CAFs have been shown to promote tumor cell metastasis in part by altering the local collagen
microenvironment. CAFs can enhance cancer metastasis in 3 ways; (1) direct association between CAFs and
leader cells within the tumor, (2) CAF mechanical alterations of the local microenvironment, and (3) CAF
secretions that can signal for tumor metastasis and collagen remodeling. How the chemo-mechanical feedback
between CAFs, cancer cells, and the ECM remains poorly understood. Here, our goal is to elucidate the
chemo-mechanical feedback function of CAFs on leader cells and the microenvironment that facilitates
directed collective cell migration. (1) Quantify the impact of CAFs on collective cell migration and ECM
remodeling. (2) To examine the effect of the CAF secretome on local collagen structure and function. We will
utilize microfluidic cell-based invasion assays in conjunction with primary breast tumor organoids or
reconstituted breast tumor organoids (non-migratory mammary cells mixed with isolated leader cells or CAFs)
to probe the effect of CAFs on collective cell migration. We will isolate the role of mechanical forces generated
by CAFs within the tumor on leader cell function and the effect of CAF generated forces on collagen
deformation and remodeling (1). We will then compare the mechanical effect of CAFs on collective migration to
that of the chemical CAF secretions on collagen remodeling (2). We aim to quantify the relative role of both
mechanical and chemical models to generate a predictive model of CAF function on collective cell migration.
We will verify this model by using engineering techniques to manipulate the microenvironment and observe the
effect on collective migration. We will combine this with biological techniques to genetically manipulate CAFs
and leader cells to identify how CAFs are capable of effecting collective cell migration.

Public health relevance
Project Narrative Breast cancer is the most diagnosed cancer among American women, an estimated 281,550 new cases of invasive breast cancer expected to be diagnosed in the United States in 2021, and 43,600 deaths will be due to breast cancer. Treatments for metastatic breast cancer are often ineffective and thus this research proposal is driven by the objective of elucidating how cancer associated fibroblasts (CAFs) modulate the chemical milieu and the biomechanics of leader cells and the surrounding environment in collective tumor cell invasion. The results of this proposal could facilitate the design of novel, more specific and effective anti-cancer therapies that target CAF-generated chemical and mechanical cues to help mitigate collective tumor migration.